Epigenetic regulation of pancreatic cancer subtype identity and tumorigenesis by PHF2

Molecular subtyping of pancreatic ductal adenocarcinoma (PDAC) has defined two major transcriptional
subtypes, Classical and Basal-like, which are presently the most powerful predictors of patient outcomes.
Thus, there is a critical need to determine the underlying mechanisms responsible for PDAC cell identity.
Our preliminary experiments demonstrate that inactivation of PHF2, a histone demethylase, in low-passage
patient-derived Classical PDAC cells results in a striking loss of the Classical gene program and virtually
abolishes tumor growth. In addition, deletion of Phf2 suppresses pancreatic tumor initiation and prolongs
survival in genetically engineered mouse models. Moreover, our CUT&RUN experiments reveal that PHF2
co-localizes on chromosomes with CTCF and SMC3, proteins that contribute to cell identity by regulating
the three-dimensional architecture of chromatin. Based on these exciting preliminary results, our central
hypothesis is that PHF2, controls the Classical gene program in PDAC by regulating three-dimensional
architecture of chromatin. Experiments in this proposal will employ a unique collection of low-passage
human cell lines, high resolution mapping of chromatin-associated proteins and chromatin architecture, and
NanoString GeoMx spatial transcriptomic analysis of genetically engineered mouse models to define the
role of PHF2 in PDAC. Three specific aims are proposed to test the central hypothesis: 1) Define the subsets
of PDAC that are dependent on PHF2; 2) Identify the mechanisms by which PHF2 regulates gene expression
in PDAC; and 3) Define the contribution of Phf2 to tumorigenesis in genetically engineered mice. In the first
aim, orthotopic xenograft tumor models allowing for the temporal inactivation of PHF2 by CRISPR/Cas9 will
be employed to determine the importance of PHF2 in the maintenance of PDAC tumors as well as their
response to chemotherapy. In the second aim, CUT&RUN, HiChIP, and RNA-seq experiments will be
employed to define the global localization of PHF2 on chromatin in PDAC cells and ascertain its role in
recruiting CTCF and cohesion to DNA to mediate DNA loop formation. For the third aim, genetically
engineered mouse models of PDAC lacking Phf2 will be used to elucidate its role in the KRAS-driven
changes in cell identity required for pancreatic acinar cells to transform to invasive cancer . Spatial
transcriptomic studies will be performed to ascertain how Phf2 deficiency alters the composition of the tumor
microenvironment by the development of PDAC that is deficient in the Classical program. The research
proposed in this application is innovative because it will define a novel function for PHF2 in regulating
chromatin architecture, further elucidating the mechanisms that allow for cell type-specific chromatin
architecture. The proposed research is significant because it will provide strong evidence for the role of
epigenetic regulation of PDAC cell identity, ultimately providing new opportunities for the development of
novel therapies for PDAC.

Public health relevance
NARRATIVE Over the past 40 years little progress has been made in the treatment of pancreatic cancer, the third leading cause of cancer-related deaths in the United States. This proposal characterizes the contribution of a protein that regulates gene expression to the biology pancreatic cancer. The insight gained from these studies will real novel mechanisms contributing to this highly chemoresistant disease and may provide new avenues for therapeutic intervention.